PARENT CONTRACT HHSN261201400011I TERMS AND CONDITIONS APPLY THIS IS A TASK ORDER FOR MEETING SUPPORT ACTIVITIES FOR THE NATIONAL CANCER INSTITUTE (NCI) CANCER INTERVENTION AND SURVEILLANCE MODELING

The Cancer Intervention and Surveillance Modeling Network (CISNET) 2022 Mid-Year Meeting was virtually scheduled for the week of May 2-May 20, 2022. A CISNET Mid-Year and Annual Meeting is mandated under the terms of the cooperative agreement that funds CISNET (U01CA253911, U01CA265739, U01CA265750, U01CA253912, U01CA253913, U01CA199336, U01CA265729-01, U01CA253858, U01CA265735, U01CA253915 ). Investigators funded under this consortium come together to discuss their joint work on the use of simulation modeling to guide public health research and priorities. There is a mid-year meeting in May/June every year at one of the consortium members institutions and the Annual meeting occurs in November or December at NIH. Attendance is mandatory for all the funded investigators, which includes ten multiple Principal Investigator (PI) grants, each with two to six PIs and associated co-investigators. In addition to the grantees, NCI program staff attend, as well as a small number of guests who speak on specialized topics relevant to the groups’ research. The consortium consists of ten cancer sites (breast, bladder, gastric, prostate, colorectal, lung, esophageal, cervical, multiple myeloma and uterine), and each group meets separately between one to three days each. These meetings overlap to some extent, but are strategically scheduled to allow those participating in multiple cancer sites to attend relevant sessions. This set-up enables participants to come only for the days that reflect their specific areas of expertise and/or participate in the entire conference without missing vital information. This year the annual meeting will be in two parts. The “Common Day” sessions which are sessions meant for all members of CISNET will be held virtually on November 9 and 10th, 2022. There are no services requested in this contract for the common day meetings. The 10 cancer site specific sessions will be held the week of December 12-16, 2022 in the Natcher Conference Center on the NIH campus in Bethesda. If the Montgomery County COVID risk level moves to high, contingency plans are in place to hold the meeting virtually, and no services will be needed under this contract.

The purpose of this award is as follows: To obtain meeting support for the in-person Annual CISNET meeting Dec 12 – 16, 2022, in the Natcher Conference Center on the NIH campus in Bethesda, MD, which will be held unless the Montgomery County risk level goes to high. If the meeting is in-person, participants will be allowed to attend virtually. Specific tasks include meeting folder preparation, preparation of name tags and tent cards, participation in meeting planning calls, and on-site staff for manning the registration desk. Delivering meeting materials and poster boards.